Realizing BRAVE-EM for Nanoscale Multicolor Imaging in Biology: Biological Real-space Absorption Visualization by photoEmission Electron Microscopy

Project Summary/Abstract
Imaging cells and tissue labeled with fluorescent molecules and proteins is critical in
biological research, enabling visualization of the locations of specific proteins, receptors,
or genotypes within cells and tissue. However, our current imaging modalities are not
capable of simultaneous functional imaging of molecules/proteins and structural imaging
of cellular and subcellular features in whole tissues, limiting both our fundamental
biomedical understanding of diseases and strategies for treatment. Leveraging recent
advances in the development of photoemission electron microscopy for high-resolution
imaging of biological tissue for volume electron microscopy, the proposed research
program seeks to develop BRAVE-EM, Biological Real-space Absorption Visualization by
photoemission - Electron Microscopy, to combine the wavelength specificity of optical
light microscopy with the spatial resolution and volume imaging of electron microscopy.
Developing BRAVE-EM will enable imaging of fluorescent molecule and protein labels in
biological tissues with spatial resolution <20 nm, while remaining compatible with recent
advances in the volume electron microscopy infrastructure. Using volume electron
microscopy and BRAVE-EM, we will answer questions in cancer biology, such as how
heterogeneity in cancer-associated fibroblasts and variations in protein expression in the
tumor stroma of pancreatic tissue samples influences cancer metabolism and disease
progression.

Public health relevance
Project Narrative Human disease is inherently heterogenous, and every cell in a person’s body has a different protein expression, presentation of antigens, and structural environment. The proposed research aims to develop microscopy techniques that will allow us to reconstruct not only the three-dimensional structural network of cells and tissues in biological material such as tumors, but also the 3D variation in molecular expression, simultaneously. Such techniques will ultimately allow us to determine how cells and tissue work, or fail to work, cooperatively in the progression of diseases such as cancer and identify new opportunities for treatment.